Cellular Dysfunction in Exfoliation Glaucoma

Project Summary/Abstract: Cellular Dysfunction in Exfoliation Glaucoma Exfoliation syndrome
(XFS) is an age-related disease involving the deposition of aggregated fibrillar material (XFM) in
extracellular matrices. Its main morbidity is in the eye, where XFM forms on the surface of
anterior segment tissues. XFM causes exfoliation glaucoma (XFG), a rapidly progressing disease
associated with approximately 1/3 of open-angle glaucoma (POAG) cases worldwide. XFG
demonstrates a sharp age-dependence in similarity to the many age-related diseases qualified
as aggregopathies. LOXL1, a matrix cross-linking enzyme that catalyzes the crosslinking of
tropoelastin for the synthesis of elastic fibers and a major component of XFM, has been linked to XFG
by Genomics Wide Association Studies, however, it is still unclear how LOXL1 protein
contributes to disease pathology.Progress in understanding the cellular basis for XFS/G has been
slowed by a lack of experimental models. Working with primary human tenon fibroblasts (TF)
derived from trabeculectomies of XFG patients and controls (age-matched POAG patients and No-
Glaucoma patients), we recently found that, XFG-TFs display many of the functional features
observed in cells from other age-related aggregopathies such as Parkinson's, Alzheimer's, and
AMD including defects in lysosomal positioning, autophagy, microtubule organization and function,
and mitochondrial health status. Linking LOXL1 to the development of XFG, we have found that
XFG-TF a) display increased LOXL1 export by a mechanism aimed at neutralizing misfolded
nascent polypeptides; b) process LOXL1 through autophagy indicating the presence of
misfolded or denatured units of this protein; c) accumulate intracellular protein aggregates with
higher endogenous expression; and d) overexpress clusterin an aggregate-responsive chaperone-
like protein. Finally, an in silico examination of LOXL1 secondary structure indicated that LOXL1
protein has elemental structures within the N-terminus that are predicted to confer an increased
aggregation propensity. Furthermore, experiments of LOXL1 whole protein or with deletions shows
that indeed LOXL1 has high aggregation propensity and that the loci of this propensity reside
within specific stretches of the N-terminus. Accordingly, we seek to answer fundamental
questions on the factors that underpin XFG pathology. We propose, SpA1) to study the molecular
machinery leading to the defects in microtubule function; SpA2) to investigate cellular stress
responses, and the connection between LOXL1 export and misfolded protein machinery, and SpA3)
to identify the minimal amino acid sequences and structural features of the LOXL1 sequence that
mediate its aggregation propensity.

Public health relevance
Project Narrative In Exfoliation Glaucoma (XFG), the leading identifiable cause of open-angle glaucoma, the eye starts accumulating protein aggregates that eventually block the exit of fluid from the eye. Our studies are the first to identify age-related cellular defects in the autophagy system and features that identify XFS as a cellular aggregopathy. In this proposal, using cells derived from XGF patients and immortalized cell lines, we will examine the putative cell biology defects and molecular sources of the disease.